Scalable Digital Communication Intervention to Support Older Adults and Care-partners Transitioning Home After Major Surgery

PROJECT SUMMARY
In this R01 proposal, we outline a comprehensive 5-year research proposal that will support development and rigorous
testing of a scalable intervention to improve integration of geriatric principles into surgical care of older adults with the
goal of improving patient and care-partner quality of life from transitions into and out of the hospital around the time of
surgery. This significant and innovative plan aims to improve care transitions for this high risk patient population as they
are discharged home after major surgery. Background: Surgeons try to prepare and support older adults through the
perioperative transitions to the hospital and back home, with variable success. Most surgeons are not fully equipped to
address geriatric needs that exist among the rising number of older adults presenting to surgical attention. Addressing
health outcomes that older adults prioritize when considering surgery is an important opportunity to improve surgical
care quality in this growing patient population through development of novel interventions. Specific aims and research
design: We aim to develop the first version of myPOSH, a digital intervention to improve the care of older patients
undergoing surgery including development of content and application with methodology for implementation through 1)
interviews with older adults undergoing major surgery and their care-partners when available (up to n=30) (Aim 1.1),
with additional input from 2) key clinical stakeholder focus groups (i.e., surgeons, geriatricians, and nurses) (n=4; at least
24 clinicians) (Aim 1.2). Next, we will examine the preliminary feasibility and acceptability of myPOSH via an open pilot
(n=20 patients, n=2 surgical teams across 2 sites) with exit interviews and pre-post assessments. myPOSH will be refined
(Aim 2). Finally, we will examine the feasibility and acceptability of myPOSH versus usual surgical care (n=84 patients; 42
patients per arm) in a pilot RCT following predetermined benchmarks (Aim 3). These findings will inform a hybrid
efficacy trial through future funding with plans to extend this work to other surgical clinic sites. Relevance: This R01 is in
line with the goal of this funding announcement to develop scalable interventions to improve care transitions among
high risk patient populations. Impact: As surgeons with expertise in surgical systems change, we recognize the critical
need to improve surgical care quality among older adults transitioning home after surgery. Experiences gained through
this proposal are foundational to future research to improve caregiver preparedness and reduce patient anxiety in the
perioperative setting.

Public health relevance
PROJECT NARRATIVE Smartphone-based education and remote self-monitoring are scalable solutions that can address unmet information needs and address poor care coordination, anxiety, and caregiver burden among older adults transitioning home after major surgery. This proposal outlines the development and refinement of the myPOSH intervention, a digital health solution to support the needs of older adults undergoing major surgery and their care-partners. The findings from this work can be scaled and spread to increase the value of care provided for a variety of health conditions and will drive future efforts to improve transitions home after major surgery.